Clinical Reporting and Research Informatics Support Services

To provide incremental funding to base period for contract Clinical Reporting and Research Informatics (CRRI) - 47QTCA20D003A-14D0420F0483 - Essex Management, LLLC